Bifidobacterium infantis supplementation in early life to improve neurodevelopment in infants exposed to HIV

Higher risk of neurodevelopmental delay during early childhood has been reported among infants who are HIV
exposed in utero but uninfected (iHEU) compared to their HIV unexposed counterparts, to which both HIV and
antiretroviral regimens may contribute. Similarly, iHEU have found to have altered gut microbiome composition,
with decreases in Bifidobacteria abundance, particularly B. infantis, and increased systemic inflammation during
the first year of life. Recent studies found that low abundance of gut Bifidobacteria during early life is associated
with increased risk of neurodevelopmental delay during early childhood in at-risk infants. As early life gut
microbiome is also crucial for immune maturation and development of cognitive function, the question arises
whether optimization of the gut microbiome during early life would be sufficient to decrease systemic
inflammation and improve neurodevelopment among iHEU. Dr Happel, a Senior Research Officer at the
University of Cape Town with expertise in molecular biology, microbiology and immunology and career
development needs in computational biology, biostatistics and epidemiology, will leverage an ongoing
randomized, double-blinded trial of oral B. infantis vs. placebo given during the first month of life to 200 iHEU
(R01HD109089). The trial provides rigorously collected clinical and biological data, a sample repository, and the
infrastructure to assess neurodevelopment and systemic inflammation in these iHEU to address this hypothesis.
Specific Aim 1: To compare neurodevelopment longitudinally in iHEU randomized to receive B. infantis versus
placebo in early life using the culturally adaptable Bayley Scales of Infant and Toddler Development, 4th edition,
at 9 and 24 months of age.
Specific Aim 2: To compare systemic inflammation longitudinally in iHEU randomized to receive B. infantis versus
placebo in early life by measuring levels of circulating cytokines previously associated with HIV exposure and
neurodevelopment at 1 and 9 months of life by Luminex.
Specific Aim 3: To identify microbial and systemic predictors of neurodevelopment in South African infants by
integrating bacterial shotgun metagenomics, stool metabolomics, T cell phenotypes, systemic microbial
translocation (generated as part of the parent trial) and plasma cytokine data with neurodevelopmental outcome
data (generated here) using multiple data driven approaches.
The proposed project will provide critical data to design further interventions of modifiable biological domains
among iHEU that may improve neurodevelopmental health of this growing population. Findings will provide
insight into the use of early-life biomarkers as predictors of neurodevelopment during infancy that could
subsequently be exploited for diagnostic tool development to identify at-risk infants. Together, this might
ultimately result in decreased morbidity of iHEU, or of other infants whose gut microbiome was disturbed during
early life. This proposal is highly relevant for sub-Saharan Africa, where >25% of infants are HIV-exposed.

Public health relevance
Narrative Infants who are exposed to HIV but uninfected (iHEU) are at higher risk for neurodevelopmental delay compared to their HIV-unexposed counterparts, and have lower gut Bifidobacterium abundance and higher systemic inflammation during early life. Here, we propose to leverage an ongoing randomized, placebo- controlled, double-blind trial to assess whether Bifidobacterium infantis supplementation during the first month of life improves neurodevelopmental outcomes via decreases in systemic inflammation, and to in identify predictors of neurodevelopment in this population. Through the use of multiple data-driven approaches integrating biological measures with clinical neurodevelopmental outcomes, this study has the potential to inform novel intervention strategies or might ultimately lead to the development of diagnostics that help identify infants at risk of poor neurodevelopment.